MBRS/SCORE at York College

York College's vision and mission statements describe it as an institution committed to academic excellence through teaching, learning, research and scholarship. One of the specific objectives in the College's 5-year plan, which is reflected in the plans of all academic departments, calls for creating an academic environment that values and encourages research and scholarship. The College envisions the MBRS/SCORE Program as a primary means of achieving this objective. The goals and objectives of the MBRS/SCORE Program are: 1) to strengthen the research infrastructure and change the College culture to support institutional research and research training by a series of activities resulting in: a) the appointment, promotion and tenuring of faculty in MBRS/SCORE biomedical disciplines, at least 75% of whom exhibit high potential for research; b) reduced workload for all new faculty in biomedical research disciplines concomitant with each faculty's development of a scholarly plan; c) at least 75% of faculty in MBRS/SCORE biomedical research disciplines participating in grantsmanship activities, 50% obtaining assistance in developing proposals, and 75% receiving start-up funding, d) all MBRS/SCORE faculty having adequate laboratory equipment, instrumentation and space; e) the York College-FDA Collaborations obtaining at least $1m in external funding for health-related research pursued by scientists from both institutions; 2) to maintain, and where possible, increase the participation of investigator-initiated research by a) increasing the number of biomedical research disciplines with MBRS/SCORE faculty from 6 to 7, b) increasing the percentage of MBRS/SCORE investigators by 25%; 3) to strengthen the research competitiveness of MBRS/SCORE faculty by a) facilitating them in meeting their respective career development plans, b) increasing their number of presentations at professional society meetings by 25%, c) increasing their number of peer-reviewed publications by 17%, increasing the number of faculty with competitive research programs i) by 29% in the SO6 mechanism and by ii) 25% in R-15 type mechanisms. To achieve these goals and objectives, York requests support for the 12 faculty submitting MBRS/SCORE proposals: 9 regulars and 3 pilots. The regular proposals come from 5 biomedical disciplines (biology, chemistry, movement science, psychology, social work) and the pilot proposals come from 3 biomedical disciplines (environmental health science, psychology, social work). Six of these investigators are continuing SO6 PIs, 2 are current pilot investigators seeking regular SO6 funding, 4 are new investigators with 1 applying for a regular SO6 and 3 applying for pilot funding. With the resources provided by MBRS/SCORE, the College can continue to strengthen and diversify its research capability and research training capability, and continue to provide expanded opportunities for underrepresented minorities in biomedical research.